The Morehouse School of Medicine's Institute of Genomic Medicine Center for Genomic Diversity

Abstract – Overall
This proposal outlines a program to establish a Center of Genomic Diversity at the Morehouse School of
Medicine (MSM). Led by the Director of the Institute of Translational Genomic Medicine (ITGM), the
program aims to enhance genomics research capacity, improve minority health outcomes, and advance
workforce education. The program focuses on elucidating novel genomic knowledge in racially and
ancestrally diverse cohorts and investigating the interplay of social and biological determinants of
health. Through multiple projects led by esteemed faculty members, the program aims to uncover
epigenetic changes related to stress and examine the utility of a diverse reference “pan”genome in gene
expression profiling. The program includes the Community Engagement Core, Genomics Workforce
Diversity Core, and Administrative Core to facilitate community education, training, and data
infrastructure. Overall, the program aims to establish a sustainable genomics research environment,
improve genomic tools for minority health research, and enhance education and dissemination efforts.

Public health relevance
PROJECT NARRATIVE - OVERALL Building upon the success and leadership of key MSM faculty researchers, who are leaders in their respective fields of genomics, we will leverage MSM institutional strategic investments for translational genomics, industry partnerships and strategic collaborations with expert genomicists to create a world-class genomics research center. We propose an innovative shared resources model for the MSM Center for Genomic Diversity (CGD) to be seated within the new MSM’s Institute for Translational Genomic Medicine (ITGM). The administrative core will be led by Dr Melissa B Davis, the contact PI/PD for this U54 Proposal, who was recruited in 2022 as the founding Director of the ITGM. A group of Associate/Assistant Directors (ADs) with complementary expertise and diversity will co-manage the operations of three tiers representing 1- Administrative, 2-Data management and 3-Technology Development. Hinged on the premise of genetic diversity among groups of distinct geographical ancestry, and focused on the MSM mission of improving minority health, the CGD will provide a pace-setting novel data set and data repository while launching a new era of genomics research across the HBCU system.